Virtual MOUD Treatment: Virtual Point-of-Care Toxicology Testing to Accompany Virtual Medication Assisted Treatment for Opioid Use Disorder

Background. Medication treatment of Opioid Use Disorder (MOUD) saves lives and is increasingly delivered
virtually. Currently, 60% of VA outpatient addiction treatment occurs over video. The pandemic accelerated this
trend, but it will be sustained through multiple VA policies. However, toxicology testing, a major component of
MOUD care, currently requires in-person visits. A process for virtual point-of-care toxicology testing is needed.
Significance. In current virtual MOUD care, toxicology testing is either not completed or requires in-person
urine testing, which is inconvenient and stigmatizing. A process for virtual point-of-care testing, which mitigates
these barriers, will be developed through this research. Such as process will be more acceptable, facilitate
patient-centered care, and decrease stigma, improving MOUD utilization and patient outcomes. This research
will directly address VA stated goals to “Improve MOUD implementation” and “Understand how to address
stigma.”
Innovation. MOUD care, which incorporates (1) virtual toxicology testing, (2) patient self-testing at the point-of-
care, and (3) oral-fluid test kits, is entirely novel. There has been no research on virtual point-of-care toxicology
testing among Veterans. In addition, virtual toxicology testing will advance other innovative addiction
treatments such as virtual contingency management.
Specific Aims. This research will develop a Virtual Point-of-Care Toxicology Testing Process for VA. AIM 1
(Pre-Pilot) will design and iteratively modify a Virtual Toxicology Testing Process, which uses oral fluid test kits.
AIM 2 (Pilot Trial) will evaluate the feasibility, acceptability, and proximal effects of the process by evaluating
provider and patient testing uptake, qualitative feedback, and health service use. AIM 3 (Scale-up) will (1)
prepare a Virtual Point-of-Care Toxicology Testing Toolkit and (2) operationalize testing for a future multi-site
randomized trial.
Methodology. Mixed-methods will be used to develop and evaluate the testing process, which will use an oral-
fluid test for common drugs of abuse. Patients will self-administer the test during virtual MOUD visits and
assess results with providers. In the pre-pilot phase, stakeholder groups of VA-wide clinical/laboratory leaders,
providers, and patients will design and iteratively modify the process. In the pilot phase, a single-arm mixed-
methods pilot trial will evaluate the process among patients and providers at two VA facilities. Feasibility will be
evaluated by examining process uptake. Acceptability will be evaluated through semi-structured interviews with
patients and providers based on Consolidated Framework for Implementation Research (CFIR) constructs.
Health service use will be evaluated by analyzing data on patient characteristics, test utilization, and treatment
contacts extracted from the electronic medical record. In the scale-up phase, the Virtual Point-of-Care
Toxicology Testing Process will be summarized in a toolkit for VA-wide distribution. The toolkit will (1) identify
tests meeting VA requirements; (2) develop education materials; (3) specify procedures for administering and
analyzing tests; and (4) specify additional activities such as confirming results, ordering tests, and documenting
results.
Next Steps/Implementation. The Virtual Point-of-Care Toxicology Testing Toolkit will be disseminated using
current VA addictions informational and didactic resources and venues. The toolkit will be operationalized for a
future multisite, randomized hybrid trial evaluating the effectiveness of virtual toxicology testing compared to
testing as usual.

Public health relevance
Medication treatment of Opioid Use Disorder (MOUD) saves lives and is increasingly delivered virtually. However, toxicology testing, a major component of MOUD care, is either not completed as part of virtual care or requires in-person urine testing, which is inconvenient and stigmatizing. A process of Virtual Point-of-Care Toxicology Testing will increase convenience, facilitate patient-centered care, and decrease stigma, improving MOUD utilization and patient outcomes. This research will design a Virtual Point-of-Care Toxicology Testing Process, using feedback from VA-wide leaders, providers, and patients. A pilot trial will evaluate the feasibility, acceptability, and proximal effects of the process by analyzing provider and patient testing uptake, qualitative feedback, and health service use. The process will be packaged into a toolkit for VA-wide dissemination, as well as testing in a future multisite, randomized effectiveness trial.